Biomedical Engineering Core

SUMMARY FOR CORE C
The Biomedical Engineering Core C will support this program project's nanotherapeutic studies. The Core
will operate from Mount Sinai under the direction of Dr. Abraham Teunissen, an expert in nanotechnology
and organic chemistry. Dr. Teunissen also has extensive expertise in leading teams of scientists through
his roles as Director of Mount Sinai’s Radiochemistry Facility and co-Director of our Nanomedicine lab. The
Core will provide trained immunity-inhibiting nanobiologics for modulating stress-induced immune
reprogramming in Projects 2 and 3. The Core will provide these nanotherapeutics on demand and arrange
their transport to all collaborators. Moreover, Dr. Teunissen’s expertise enables this Core to efficiently
respond to newly discovered therapeutic targets by developing novel nanoformulations.